Whole Genome Sequencing of N. gonorrhoeae from Non-Culture Based Clinical Specimens to Surveil for Emerging Resistance

Project Summary
Drug-resistant Neisseria gonorrhoeae (NG) is listed as one of the 5 Urgent Threats in the US by the CDC and
one of 6 pathogens determined as high priority by WHO. Multi-drug resistant NG (MDR-NG) has emerged in
the US and globally and there is strong evidence that strains of MDR-NG can spread within dense community
networks of men who have sex with men. While urogenital NG infections typically dominate surveillance data
due to ease of sampling (urine, non-invasive vaginal swabs) and high frequency of exposure at these sites,
extra-genital sites of infection (i.e., throat, rectal) are critical to detect emerging strains of NG with reduced
antimicrobial susceptibility. During the COVID-19 pandemic, NG rates dramatically increased, with heightening
racial and ethnic disparities. To effectively disrupt NG transmission and increasing rates of resistance, we
need to improve our surveillance of emerging resistance and understanding of community spread. Whole
genome sequencing (WGS) is a powerful epidemiologic tool for a range of pathogens. While WGS for
bacterial cultures is streamlined and performed readily by labs, applying this methodology to NG-an organism
for which cultures are not regularly used in clinical care-is challenging, leading to a significant gap in
knowledge of NG spread. Furthermore, public health surveillance for antimicrobial-resistant NG largely relies
on cultures for a narrowly defined population, limiting representativeness. Creating a pipeline to make WGS of
NG directly available from non-culture based urine and extragenital clinical specimens would improve
surveillance for emerging resistance and in future work, significantly alter the landscape of understanding NG
spread. Funds are requested to use WGS for non-culture based clinical urine and extragenital specimens to
enhance detection of emerging resistance in strains of NG. We anticipate that sequencing of routinely
collected clinical NG specimens, including those from extragenital sites, will allow for surveillance of
populations often excluded from traditional culture-based surveillance, thus enhancing our ability to detect NG
strains with reduced antimicrobial susceptibility. Our study will utilize NAAT-positive NG specimens from Cook
County Health-the county's safety-net healthcare network and its dedicated Sexual Health Clinic. The
proposal has two aims: (1) Establish workflows for rapid and inexpensive WGS of NG directly from urine,
throat, and rectal specimens collected as part of clinical care, and (2) Evaluate non-culture based molecular
surveillance as an approach to enhance detection of emerging strains of NG with reduced antimicrobial
susceptibility. Our findings will be broadly generalizable to healthcare centers across the US, most of whom
routinely employ NAAT testing as their first-line method for NG testing. Knowledge gained would inform the
merits of different strategies for enhanced NG surveillance, increase the timeliness of detection of emerging
variants of concern, and maximize reach to communities most at risk. Since NG is a high priority CDC and
WHO pathogen, our proposal has significant public health impact.

Public health relevance
Drug-resistant Neisseria gonorrhoeae is listed as one of the 5 urgent threats in the US by the CDC and one of the 6 high priority pathogens by the WHO. The objective of this project is to create workflows to sequence N. gonorrhoeae from non-culture based clinical urine and extragenital specimens and use phylogenetic analysis from resulting genomic data to enhance detection of emerging strains of N. gonorrhoeae with reduced antimicrobial susceptibility. Knowledge gained would transform future genomic N. gonorrhoeae studies by allowing us to better understand transmission networks across broader reaches of risk groups who are often excluded from traditional culture-based surveillance.